MSCS ENGINEERED TO PRODUCE BDNF AND GENE EDITING CARGO FOR THE TREATMENT OF HUNTINGTON'S DISEASE

Abstract
Huntington's disease (HD) is a neurodegenerative disorder with no cure, and there is a critical unmet need for disease-
modifying treatments. We are developing a novel therapy for HD: implantation of human Mesenchymal Stem/Stromal Cells
(MSCs) engineered to secrete Brain-Derived Neurotrophic Factor (MSC/BDNF), a growth factor needed in the degenerating
striatal regions of the brain, along with gene editing cargo to specifically reduce levels of production of the mutant RNA and
protein. BDNF is low in humans and mice with HD, and up- regulation of BDNF in the brains of transgenic rodent models of
HD has ameliorated the disease phenotype. Due to pro-survival effects in striatal neuropathology, BDNF is a strong
candidate for neuroprotective therapies. Our labs have also developed targeted gene silencing tools using a novel variant
of Cas9 (xCas9 3.7) that allows for broad protospacer adjacent motif (PAM) targeting. We have demonstrated this platform
is effective in reducing huntingtin when fused to a powerful transcriptional repressor, KRAB. We have demonstrated that
MSCs are an excellent delivery vehicle. We are testing injection via the cisterna magna as a surrogate for spinal cord/CSF
fluid delivery in future patients who might receive this cell and gene therapy product developed by our team. Cellular
Nanoengineered xCas9 Therapy (CellNeXT) combines the beneficial effects of MSC administration to the striata with the
benefits of BDNF production while in combination reduction levels of mutant huntingtin. Unlike BDNF delivery via direct
vector injection or protein administration into the brain, MSCs migrate into the areas of damage and have numerous
beneficial effects. Although optimized MSCs will not persist longer than several months, we hypothesize that the
neurorestorative effects of BDNF will outlast the survival of MSCs. This is supported by animal data from our laboratory and
others. In our double-blinded efficacy studies, intrastriatal delivery of human MSC/BDNF significantly reduced anxiety and
significantly increased neurogenesis in immune suppressed HD mice, with increased survival, in comparison to vehicle
treated HD mice. We have demonstrated that treatment with MSC/BDNF decreased striatal atrophy as compared to vehicle
treated HD mice (PMID:26765769). This recovery may be due to the stimulation of endogenous neurogenesis promoted by
BDNF and enhanced by the secretion of various complementary therapeutic factors by the MSCs. In the planned studies,
we will perform the following studies in support of an investigational new drug filing to the FDA: in Aim 1 we will evaluate
the selectivity and durability of xCas9 in patient iPSC-derived NSC and neurons. In Aim 2 we will assess dose and route of
administration of CellNeXT in our novel HD mouse model. Our studies will define reproducible techniques and methods, at
the level of Good Laboratory Practice, for evaluation of cell and gene therapy candidates to be used in neurodegenerative
disorders. We will be positioned to move the CellNeXT candidate into clinical trials for HD initially, and to assist others in
using the product for additional disorders in the future. We will better define mechanism of action of CellNeXT and will define
potency assays, using reduction of mutant huntingtin and preservation of striatal atrophy as key readouts.

Public health relevance
Project Narrative In accordance with the mission of the National Institute for Neurological Disorders and Stroke (NINDS) this grant will seek fundamental knowledge about the brain and nervous system and will use that knowledge to reduce the burden of neurological disease, specifically the feasibility of a novel delivery platform for epigenetic DNA-binding domains such as CRISPR/Cas9. This research holds great relevance for the advancement of treatment for those suffering from genetically-linked neurological disorders. The funds used for this research award will be used to develop a research pathway to critically evaluate an engineered stem cell delivery platform in a translationally relevant animal model to facilitate this approach towards clinical trials.